Diversity Supplement to DP2AT011965

PROJECT SUMMARY
Our modern food environment, with its widespread availability of energy-dense, palatable foods and associated
cues, is thought to interact with our physiology to promote food intake. This has contributed to the drastic increase
in obesity in the United States over the past several decades. However, most pharmacological weight loss
strategies target satiation pathways, not sensory pathways, and therefore may be less effective at eliminating
effects of environmental/sensory cues on food intake. Here we propose to take a novel approach to
understanding the drive to eat by examining the neural integration of sensory and nutritive food signals. First,
we will create sensory “engrams” – functional maps of neurons activated by discrete sensory stimuli – and
determine how activating or inhibiting these circuits can influence food preference. Next, we will monitor calcium
dynamics in individual neurons to reveal the activity patterns that integrate sensory and nutritive information in
the brain across different body weights. These studies will reveal fundamental principles of how food information
is integrated in the brain to drive feeding behavior, revealing new targets for the development of obesity
therapeutics. We are applying for an additional year of supplemental funding to enable Ms. Alexandra Vargas, a
first-generation, low income, Latinx U.S. citizen to continue to perform research on the neural underpinnings of
feeding behavior, add new complementary neuroscience techniques to her technical repertoire, and further
develop receive writing, presentation, and networking skills. In this second year, Ms. Vargas will also gain
valuable mentorship experience, as she will help with training and mentoring Alhadeff lab high school and
undergraduate students from underrepresented backgrounds as they embark on their own research journeys.
We believe that this additional year of comprehensive technical, career development, and mentorship training
will give Ms. Vargas a competitive edge as she applies for M.D./Ph.D. programs in neuroscience to start in fall
2024. Overall, this funding will facilitate the career of Ms. Vargas, an extremely impressive and talented rising
scientist, giving her the opportunity to make major advances in the fields of neuroscience and obesity while
increasing diversity in NIH health-related research.

Public health relevance
PROJECT NARRATIVE We are constantly exposed to compelling food cues – such as the smell and taste of highly palatable foods – that interact with our physiology to promote feeding and weight gain. Here, we take a unique approach to understanding obesity by (1) evaluating the power of taste, smell, and nutrient neural circuits in modifying eating behavior, and (2) uncovering how sensory and nutritive information is integrated in the brains of awake behaving mice. An additional year of supplemental funding will enable the continuation of technical and conceptual development of Ms. Alexandra Vargas, a first-generation, low-income, Latinx U.S. citizen and aspiring physician- neuroscientist, as she works toward her goal of getting accepted into a M.D./Ph.D. program and pursuing an academic career.